Pilot Study Administration

A. Specific Aims This pilot project was funded to provide additional administrative support for the additional pilot projects funded as subcontracts through the University of Colorado at Denver and Health Sciences Center.